Developing novel therapies to improve blood stem cell transplantation outcomes

PROJECT SUMMARY
Acute Graft-versus-host disease (aGVHD) is a frequent and lethal complication of allogeneic hematopoietic
stem cell transplantation (allo-HSCT) in which donor T cells destroy HLA mismatched host tissues by secreting
inflammatory cytokines (TNF-α and IFN-γ) and/or inducing direct cytotoxic cellular responses. Despite recent
advances, aGVHD still remains a major clinical problem, underscoring the need to elucidate further its
mechanisms to then develop novel therapeutic strategies. In this proposal, we are investigating epithelial
growth factor like 7 (EGFL7) as a potential modulator of aGVHD. EGFL7 is a repressor of endothelial cell
activation which plays an important physiological role in angiogenesis. Recently, it has also been documented
that EGFL7 plays a significant role in regulating inflammation by repressing endothelial cell activation in
response to the inflammatory cytokines such as TNF-α. The repression of endothelial cell activation by EGFL7
results in reduced expression of cellular adhesion molecules such as ICAM-1, VCAM, and E-Selectin, which
results in reduced adhesion and extravasation of inflammatory cells into target tissues. Based on these data,
we hypothesized that increasing EGFL7 levels after allo-HSCT will diminish the severity of aGVHD by
interfering with the migration of T cells to the target tissues. Our preliminary data showed that treatment
with recombinant EGFL7 (rEGFL7) in two different murine models of aGVHD decreases aGVHD severity and
improves survival in recipient mice after allogeneic transplantation with respect to controls without affecting
graft versus leukemia (GVL) effect. Furthermore, we showed that rEGFL7 treatment results in higher
thymocytes, T, B and dendritic cells in recipient mice after allo-HSCT. Overall, our preliminary data support a
role for EGFL7 in the modulation of aGVHD. In this proposal, we would like to dissect the mechanisms by
which EGFL7 modulates aGVHD and impact on immune BM reconstitution and to perform preclinical studies
using rEGFL7 as a therapy to prevent and treat aGVHD. We are planning to achieve these goals by performing
the following aims: Specific Aim 1: To dissect the mechanisms by which EGFL7 modulates aGVHD and
impact on immune reconstitution. In this aim, we will systematically assess endothelial cell activation status
and T cell phenotypes in murine models of aGVHD after EGFL7 therapy. Furthermore, we will explore whether
EGFL7 has any direct effects on T cell function and intestinal stem cells. Last, we will investigate the EGFL7
effects on immune reconstitution. Specific Aim 2: To perform preclinical studies using rEGFL7 as a
therapy to prevent and treat aGVHD. In this aim, we would like to perform initial toxicology, pharmacokinetics
and pharmacodynamic studies to select the best dose and schedule to prevent and treat aGVHD. In addition,
we would like to investigate whether rEGFL7 therapy is effective in a steroid refractory aGVHD murine model.
Impact: The identification of EGFL7 as new therapy for GVHD will benefit primarily patients undergoing allo-
HSCT to cure hematologic malignancies.

Public health relevance
PROJECT NARRATIVE The goal of this proposal is to elucidate the role of EGFL7 in the biology of acute Graft versus Host disease (aGVHD) and developed therapeutic strategies to target this protein. At completion of this project, we will have an increased understanding of the role of EGFL7 in aGVHD and incorporate these findings into future treatment strategies that may improve overall outcomes.